FY26 FFRDC LEASES

The Contractor shall execute, operate, and administer all leases and lease
related requirements identified herein.

NCI Lease Facilities:
8560 Progress Drive, Frederick, MD 21702
4600 Wedgewood Blvd., Suites H, K, N and M, Frederick, MD 21703
Building 425, Ft. Detrick, Frederick, MD 21702
2099 Gaither Rd., Rockville, MD

NIAID Lease Facilities:
5705 Industry Lane, Frederick, MD 21704
7114 Geoffrey Way, Frederick, MD 21704
7116 Geoffrey Way, Frederick, MD 21704
Building 310, Ft. Detrick, Frederick, MD 21702
Building 315, Ft. Detrick, Frederick, MD 21702